Microfluidic Droplet Organoids to Decipher the Tumor Heterogeneity in CRC of African Ancestry

Abstract
Colorectal cancer is the third most common cancer and the third leading cause of cancer deaths in the US
and the incidence of colorectal cancer in African Americans is higher than the general population. Furthermore,
survival among African American patients with colorectal cancer remains significantly lower than other racial
groups. Therefore, colorectal cancer in African American patients still remains a debilitating disease and there
is an unmet need to further understand the biology and specifically tumor heterogeneity of this disease to develop
new therapeutic approaches for these patients in order to improve treatment and overall prognosis. In our
preliminary work, we have developed a droplet-based microfluidics based technology to generate miniature
droplet organoids (MDO) that can be used to grow single cancer cells to study tumor heterogeneity and drug
resistance. Thus, our overall hypothesis is that MDO is the only method that can be used to systematically
study tumor heterogeneity both functionally and genomically. We now propose to test our hypothesis by 1)
Generating miniature droplet organoids (MDO) from patients of African ancestry with CRC in order to perform
high-throughput drug screens to study tumor heterogeneity and 2) Systematically characterize the epigenomes
of the clonal CRC MDO populations and associate them with tumor growth heterogeneity and resistance to
therapy. In summary, these studies will take important steps toward understanding tumor heterogeneity in order
to develop and validate new and potent therapies in African American colorectal cancer patients that can be
successfully translated into the clinic.

Public health relevance
Relevance Survival among African American patients with colorectal cancer remains significantly lower than other racial groups in the United States. After adjustments for differences in cancer screening and access to care, colorectal cancer in African American patients appears to be a more aggressive disease. To date, there have been minimal studies to study the biology of African American patients to develop new therapeutics. The completion of this proposal will have three positive impacts for future treatment of colorectal cancer in African American patients. One, we will have characterized the tumor heterogeneity of CRC in African American patients. Second, we will have established whether targeting epigenetic changes could be a novel approach to target colorectal cancer in African American patients. Finally, we will have developed novel preclinical models of African American colorectal cancer that can be used to test new and novel therapies.